Proximity Copy Paste: A methodology for single-molecule analysis of chromosome structure

Proximity Copy Paste: a methodology for single-molecule analysis of
chromosome structure.
Abstract
Genomics assays that report protein occupancy or the 3D arrangement of crosslinked and
fragmented chromosomes are often used to understand how genomic information is accessed,
copied, or repaired. While powerful, such methods only interrogate a small fraction of the available
information in a sample. Important questions related to whether events are coincident or mutually
exclusive; or the nature of cause-effect relationships are difficult or impossible to assay. This
proposal details the development of novel approaches to map the folding and protein occupancy
of entire chromosomes, with single-nucleosome resolution and single-molecule precision. Our
method employs a proximity labelling approach that can uniquely and indelibly tag DNA, protein
or other molecules that associate in 3D space. Importantly, the method can easily be tuned to
different resolutions, to allow quantitative measurements of proximity over a range of distances.

Public health relevance
Project narrative. Failure to correctly organize the genome within the cell is associated with a variety of human diseases. This project details the development a new method to map how genomes are folded within a cell. The new method will allow important questions to be investigated with unprecedented detail - allowing new insights into key elements of human disease.